SonoHeal: Smart Resonating Closed-loop Airway Clearance Technology

Project Summary
Cystic Fibrosis is a genetic disorder that affects 30,000 patients in the USA with an average life span of 37 years
and the majority (85%) of the mortality is a result of lung disease1. Airway Clearance Therapies (ACT) are extensively
used by patients for forceful mechanical clearance of mucus accumulated in airways using high pressure and high
frequency vibrations2. However, the use of ACTs is tedious, inconvenient, and poses a tremendous burden on patients
who are recommended to perform ACTs several times daily4,5. Without effective ACT, the mucus-plugged airways trap
bacteria causing infections, inflammations, respiratory failures, and other complications. ACT is also used by patients
with lung conditions where mucus clearance is necessary (e.g. bronchiectasis, COPD, Asthma).
ACT works on the principle of vibrating the lungs to increase mucus mobility. Ideally, the therapy needs to be
individualized and continuously adaptive for effective clearance. However, none of the current ACT devices and
techniques, including chest physiotherapy, high-frequency chest compression, oscillation, and acoustic vibration
therapies, are adaptive. The challenges with current ACT devices:
1. Brute-force approach: Patients have diverse airway geometry, mucus accretion levels, and obstruction locations.
Optimal therapy requires input frequencies to match the resonant frequency of specific airways to target mucus
clearance. Current ACT devices work on a set vibration pattern (Vest, oPEP, CPT) or a “feeling-based” subjective
tweaking of input frequencies and airway location (Frequencer, VibraLung), often rendering them ineffective. 2.
Subjective Assessment: None of the current devices measure lung function to provide a quantitative assessment of the
airway obstruction or therapy progress putting the burden on the patient to determine treatment effectiveness. 3. Poor
Quality of Life: As a result, patients perform uncomfortable ACT for long durations to see a positive effect, leading to
poor adherence to ACT. Further, home ACTs are considered ineffective for a large segment of the patient population
due to the lack of personalized treatment.
Cognita Labs’s proposed solution, SonoHeal, will be the first device to adapt the treatment in real-time based on the
patient’s lung status, such that the right airways are targeted for stimulation/vibration to reduce the reliance on
patient’s guesswork as well as provide effective therapy by localizing airway clearance. SonoHeal will utilize Cognita’s
patent-pending airway monitoring technology that measures airway obstruction in real-time. Combined with quantified
lung response with mucus localization information, SonoHeal will algorithmically tune the right resonant frequency to
target patient’s airways and promote effective mucus removal. In this proposal, Cognita’s team will bring years of airway
modeling, device technologies and commercialization experience to build the devoce, conduct in-vitro experimentation
on multiple lung models and validate in a human trial. Sonoheal’s goal is to improves adherence, delivers ACT
adaptively, comfortably in a shorter period and quantitatively for each patient individualized to their physiology.

Public health relevance
PROJECT NARRATIVE Airway Clearance Therapies (ACT) are critical daily requirement for Cystic Fibrosis patients to remove mucus from the lungs and avoid infections and pulmonary exacerbations. Current ACT devices work on the principals of violently vibrating/shaking the lung which leads to ineffective, uncomfortable and long therapy times. Cognita’s SonoHeal will be the first closed- loop innovation that will listen to the lung response while adaptively changing acoustic vibrating pressure waves to target the resonant frequencies of the individual airways to reduce therapy time, intensity and promote adherence.